Cannula Tip with Integrated Volume and Pressor Sensors for Rotary Blood Pump Control

Project Summary / Abstract
The use of left ventricular assist devices (LVADs) has been a viable therapeutic option for end-stage
heart failure patients. These devices are commonly used as bridge-to-transplant or destination therapy,
and as the risk of adverse events has been reduced with improved device design, LVAD support is being
considered as an option for class III heart failure patients as well. Recently, the use of continuous flow
LVADs has become common due to their small size and improved reliability. However, control of these
devices can be challenging as opposed to the previous generation of pulsatile devices. Current control
systems operate the pump at a fixed speed set by the clinician. The speed is set high enough to provide
adequate circulatory support but not too high as to cause suction and ventricular collapse. These control
systems cannot increase flow in response to physiologic demand and therefore, patients with these
devices have limited exercise capacity. As patients are now leaving the hospital and returning to their
daily activities, a control system that responds to patient demand is necessary. The major impediment to
control system development is the availability of implantable sensors capable of assessing ventricular
unloading. The primary objective of the proposed research is to develop a “smart” cannula tip with
integrated sensors for measuring the pressure and volume of the left ventricle. A control algorithm will be
developed to adjust pump speed based on the sensor data obtained from the cannula tip. The control
algorithm will adapt pump flow to changes in circulatory demand in order to maintain ventricular
unloading, provide adequate blood flow, and prevent adverse suction events. The experience and
expertise of the Penn State Division of Artificial Organs in the development of LVADs and implantable
electronics will be utilized to develop and fabricate the proposed device. A prototype cannula tip and
control system have been tested in acute ovine studies with the HeartMate II LVAD. We propose to
evaluate the biocompatibility of the device, stability of the volume and pressure sensors, and functionality
of the automatic control system in a series of acute and chronic ovine studies.

Public health relevance
Project Narrative Heart disease is the number one cause of death in the United States with over 500,000 deaths per year. Due to insufficient donor heart availability, the use of left ventricular assist devices (LVADs) has been a viable therapeutic option for end-stage heart failure patients. The proposed research is to develop a “smart” cannula tip for LVADs that can measure left ventricular volume and pressure in order to adapt pump flow to the patient’s circulatory needs and minimize the risk of adverse events.